National Research Service Award

ABSTRACT
Over the past 37 years, Brown University's AHRQ-supported Institutional T32 Training Program has developed
over 70 interdisciplinary and highly productive pre and post-doctoral health services researchers. Nearly all
former trainees are employed in faculty, government or private sector research positions. Our last two awards
provided support for pre-doctoral trainees in health services research, and we capitalized on that opportunity to
successfully recruit talented students who have now become promising health services researchers. We
attribute our success in both pre- and post-doctoral training to: 1) attracting and recruiting high quality, diverse
applicants; 2) an individualized training experience to meet trainee goals; 3) a mentoring strategy consistent
with multidisciplinary work; 4) an organizational culture of synergy between training and research missions; 5)
an extensive research portfolio ($42 million in 2022); and 6) over 30 multidisciplinary faculty committed to pre
and post-doctoral training. Major changes in health care policy and delivery system reform make it essential to
have well trained researchers operating in academic, government and private sector settings who understand
the factors shaping these trends and who have the skill to evaluate their impact and design alternative
approaches. To address this need, our training program aims to produce health services researchers who
have the leadership skills and methodologic expertise to inform policy, improve health system performance,
and, promote better population health outcomes. Specific objectives of this training program are: 1) To recruit
highly qualified and socio-demographically diverse post- and pre-doctoral trainees; 2) To develop scientists
experienced in the use of state-of-the-art health services research methods, with specific foci in evidence-
based medicine, comparative effectiveness research, chronic disease and aging, etc.; 3) To develop scientists
skilled in the communication of scientific knowledge who are able to work in multidisciplinary teams in
academia, government and the private sector; 4) To provide didactic as well as "hands on" supervised
experience in research by matching trainees with externally funded research teams; and, 5) To develop
scientists equipped with the leadership skills to improve health care delivery and influence health policy.

Public health relevance
Project Narrative Our training program aims to produce health services researchers who have the leadership skills and methodologic expertise to inform policy, improve health system performance, and promote better population health outcomes.